(PQ3) Addressing Cancer Treatment Disparities for Persons with HIV

PROJECT SUMMARY/ABSTRACT
The introduction of combination antiretroviral therapy (ART) has led to a dramatic decline in AIDS-associated
mortality. However, as persons with HIV (PWH) age, mortality from non-AIDS-defining cancer (NADC)
continues to increase and is now the leading cause of death for PWH. Recent studies have demonstrated
persistent disparities in both initiation of cancer therapy and survival among PWH and cancer compared with
the general population. This may be due in part to medical and radiation oncologists' concerns regarding the
safety and efficacy of cancer treatment for PWH. Alternatively, it is possible that chemotherapy with radiation
therapy (CRT) and radiation therapy (RT) alone may be less effective in PWH or associated with greater
toxicity. It is well established that positive cancer outcomes are dependent on successful navigation of all steps
in the cancer care delivery process, including: timely treatment initiation, treatment completion, and treatment
safety, defined by avoidance of serious adverse events (SAEs). It is also critical to evaluate the ongoing health
needs of cancer survivors with HIV, including the risk of long-term chronic health conditions (i.e., late adverse
effects) after cancer treatment. Prior studies have evaluated cancer treatment initiation rates for certain
cancers, however, there have been no published studies that have comprehensively evaluated differences in
outcomes at other key steps in the cancer care delivery process for PWH compared with people without HIV
(HIV-), nor have there been studies that have evaluated patient- and provider-factors that might contribute to
disparities at each step. We propose the following Specific Aims which will address these critical knowledge
gaps for the four most common NADCs in PWH treated with CRT/RT (anal, head and neck, lung, or prostate
cancer): Aim 1: To evaluate differences in the timing of cancer treatment initiation between PWH and matched
HIV- with cancer, and risk factors for delayed treatment in PWH. Aim 2: To evaluate disparities in short-term
SAEs and cancer treatment completions between PWH and matched HIV- patients who initiated CRT/RT. Aim
3: To evaluate the long-term risk of mortality and cancer recurrence comparing PWH with cancer and matched
HIV- patients. Aim 4: To compare risk of chronic health conditions among PWH with cancer, with (a) HIV- with
cancer and (b) PWH without cancer. In addition to evaluating differences in outcomes between PWH and HIV-
patients with cancer, study aims will also evaluate the impacts of key potential risk factors, including: ART
regimens, immunosuppression, and treatment dosage and completion, which may be associated with CRT/RT
outcomes. This observational cohort study will identify >3,000 PWH diagnosed with cancer, 1:1 matched HIV-
persons with the same cancers, and 4:1 matched PWH without cancer who have received care from the
Veteran's Administration or Kaiser Permanente, the two largest single-payer integrated healthcare systems in
the United States. Study findings will provide data to provide targets for cancer care delivery and treatment
interventions, and inform HIV-specific cancer treatment guidelines to improve cancer survival among PWH.

Public health relevance
PROJECT NARRATIVE People with HIV (PWH) may have poorer cancer outcomes than people without HIV (HIV-), but few large studies have evaluated differences in specific cancer care delivery outcomes by HIV status. Within the Veteran's Administration and Kaiser Permanente, we will investigate reasons for disparities between PWH and matched HIV- persons in delays in cancer treatment initiation, completion and safety, as well as short- and long-term outcomes of cancer recurrences, mortality, and risk of chronic health conditions. Study findings have potential to identify intervention targets, inform HIV-specific cancer treatment guidelines, and improve cancer care delivery and outcomes for PWH.